Dermatomal Mapping with Spinal Cord Functional Magnetic Resonance Imaging

PROJECT SUMMARY/ABSTRACT
Radiculopathy is a common spinal condition resulting from compression and irritation of the spinal nerve roots,
leading to sensory deficits, muscle weakness, and pain. Dermatomal maps are a key component of the clinical
exam and provide information on the correspondence between cutaneous sensations and the nervous system.
Dermatomal sensory deficits can help localize neurological injury in spinal conditions and guide treatment.
Dermatomal maps, however, are limited—they contain uncertainty in the neuroanatomy mapped (spinal nerve,
dorsal root ganglion, dorsal horn, or spinal cord (SC) segment), assume left-right symmetry and no sex
differences, provide no information on between-subject variability, and remain to be validated. SC functional
magnetic resonance imaging (fMRI) permits the non-invasive in vivo spatial mapping of human SC activity.
Here we will use SC fMRI to test hypotheses central to dermatomal maps, investigate the effects of
neurological injury on SC sensory processing, develop markers of SC sensory activity, and test their diagnostic
value in cervical radiculopathy while improving our SC fMRI methods. To accomplish this, we will first enhance
our existing SC fMRI methods by building a research-grade 64-channel head-neck coil, testing a novel spatial
normalization method that accounts for SC segment location, and exploring the use of surface
electromyography to monitor and remove motor-related noise during fMRI experiments. We will compare the
improved SC fMRI methods against our currently operational methods while characterizing the SC correlates
of sensory stimulus intensity encoding using electrocutaneous sensory stimulation of the third digit of the right
hand (C7 dermatome) in 30 healthy volunteers (HV) (20-79 years old, 15 females, 15 males). Then using the
enhanced SC fMRI methods, we will quantitatively map the spatial distribution of SC activity in 120 right-
handed HVs (20-79 years old, 60 females, 60 males, stratified by age) during electrocutaneous sensory
stimulation of the first, third, and fifth digits (C6, C7, and C8 dermatomes, respectively) of the left and right
hands. We will develop probabilistic maps of the spatial distribution of SC activity, assess the superior-inferior
localization of activity, contrast the activity between left and right stimulation and sexes, and quantify between-
subject variability. We will use machine learning algorithms to develop normative SC sensory markers by
predicting the stimulation site. Finally, 40 right-handed patients with right-sided C7 cervical radiculopathy (30–
79 years old, 20 females, 20 males) and 40 age- and sex-matched HVs will also undergo the same SC fMRI
experiment, and we will investigate group differences in SC activity to uncover the effects of neurological injury
on SC sensory processing and then assess the diagnostic value of the SC sensory markers. Completing our
aims will improve SC fMRI methods, validate/refute hypotheses central to dermatomal maps to better inform
their use in clinical practice, advance our scientific knowledge of SC sensory processing in healthy and injured
states, and provide preliminary validation of MRI-based diagnostic markers for cervical radiculopathy.

Public health relevance
PROJECT NARRATIVE Radiculopathy is a common spinal condition resulting from compression and irritation of the spinal nerve roots, leading to sensory deficits, muscle weakness, and pain. Clinicians use dermatomal sensory testing to localize the level(s) of nerve root injury in radiculopathy; however, dermatomal maps are limited and remain to be quantitatively validated. Here we will use spinal cord functional magnetic resonance imaging (fMRI) to test hypotheses central to dermatomal maps, advance our knowledge of spinal cord sensory processing in healthy and injured states, and provide preliminary validation of diagnostic markers for radiculopathy while improving our spinal cord fMRI methods.